Regulation of androgen receptor signaling in prostate cancer by protein arginine methylation

PROJECT SUMMARY
Prostate cancer is the second most common cause of cancer death among men in the United States. While
early-stage prostate cancers often respond to hormonal therapy, a subset progresses to an incurable “castration-
resistant” state (CRPC), which is resistant to standard hormonal therapies. A defining molecular feature of CRPC
is the reactivation of androgen receptor (AR) signaling, indicating that the AR remains central to prostate cancer
pathogenesis across disease states. Therefore, novel means of ablating AR signaling can inspire new treatment
strategies for CRPC. Through a genome-scale CRISPR/Cas9 screen, we identified the protein arginine
methyltransferases 1 and 5 (PRMT1/PRMT5) as novel regulators of the AR pathway. Both PRMT1 and PRMT5
modulate diverse biological processes, including AR signaling, through post-translational modification of
substrate proteins on arginine residues. As small molecule inhibitors of PRMT1 and PRMT5 have recently
entered clinical development, this pathway can also be therapeutically modulated in patients.
This proposal tests the hypothesis that PRMTs may have a specific role in regulating AR-driven transcriptional
programs through direct effects on AR and/or its co-factors, and that combination therapy with PRMT inhibitors
and direct AR antagonists may be an effective therapeutic strategy in advanced prostate cancer. In Aim 1, we
will dissect the molecular mechanisms by which PRMT1 and PRMT5 regulate AR signaling. Specifically, we will
compare the effects that PRMT1 and PRMT5 have on AR signaling in various cellular contexts. We will then
investigate roles for these PRMTs in modulating AR signaling at various nodes, including histone modification,
chromatin architecture, modification of AR co-regulators, and modification of the AR itself. In Aim 2, we will
establish the therapeutic potential of combining PRMT1 and/or PRMT5 inhibitors with an AR antagonist in in
vitro and in vivo prostate cancer models. Since our preliminary data indicate that both PRMT1 and PRMT5
modulate AR signaling, we hypothesize that inhibiting both enzymes in combination with direct inhibition of AR
may be an effective strategy to treat castration-resistant prostate cancer and to delay the emergence of castration
resistance. Moreover, prior studies have shown that the combination of PRMT1 and PRMT5 is synergistic and
well-tolerated in preclinical in vivo models. We will therefore test the activity of direct AR antagonists in
combination with PRMT1 and/or PRMT5 inhibitors in in vivo patient-derived xenograft models of hormone-
sensitive and castration-resistant prostate cancer. Finally, we will interrogate the relationship between PRMT1,
PRMT5, and AR expression in clinically-annotated prostate cancer tissue specimens and in large-scale prostate
cancer sequencing datasets.
These experiments will validate PRMT1 and PRMT5 as therapeutic targets in prostate cancer and will lend
insight into the mechanisms by which AR signaling is regulated. Overall, this work advances a mechanism-driven
therapeutic hypothesis with the potential to improve outcomes for patients with advanced prostate cancer.

Public health relevance
PROJECT NARRATIVE Prostate cancer is the second most common cause of cancer death among men. Alterations in androgen receptor signaling are pervasive in advanced prostate cancer. This proposal seeks to understand the mechanisms that regulate the androgen receptor with the goal of inspiring novel prostate cancer therapeutic strategies.